Defining the interplay of interferon-gamma and cathepsin S in age-related dry eye

With increased life expectancy, debilitating diseases that accompany aging are also expected to rise,
and one of them is dry eye disease. Increased age has repeatedly been associated with dry eye,
although the precise mechanisms by which aging predisposes to dry eye disease remain unknown.
Aging is accompanied by clinical, and sometimes sub-clinical chronic inflammation on the ocular
surface and lacrimal gland (LG). The impact of age related dry eye disease is significant because it
affects functional vision, as well as mobility, independence and the ability to perform daily tasks.
Cathepsin S is a potent cysteine/protease expressed in the lysosomal compartments of both dendritic
cells and LG acinar epithelia. Cathepsin S participates in physiological MHC II antigen presentation.
Elevated levels of cathepsin S have been described in animal models and patients with Sjögren
Syndrome and also in other animal models of autoimmunity, where it is thought to facilitate generation
of autoreactive CD4+ T cells. Our preliminary data suggests that Cathepsin S is elevated in aging.
However, the specific role of cathepsin S in the aged ocular surface and LG has not been elucidated.
We hypothesize that age-related inflammatory changes in the ocular surface and LG lead to
increased activity and production of cathepsin S by acinar epithelia and dendritic cells. This increased
cathepsin S may 1) act in a paracrine fashion to amplify local inflammation and secretion of cytokines
by the epithelium that can further increase cathepsin S creating a vicious circle; and 2) increase MHC
II antigen presentation by aged dendritic cells, skewing them to prime pathogenic CD4+IFN-γ+ (Th1)
cells that promote development of age-related dry eye disease. To investigate our hypothesis, we
propose three specific aims: Specific Aim 1: how age-related inflammation in the ocular surface and
LG stimulates cathepsin S production that promotes development of dry eye? Specific Aim 2: how age-
related increase of cathepsin S modulates dendritic cell function and promotes the generation of
autoreactive, pathogenic Th1 cells? Specific Aim 3: can cathepsin S inhibition modulate age-related
dry eye? Results from these proposed experiments will improve our understanding of the fundamental
mechanisms of age-related dry eye disease. Furthermore, it will change our view of aging on the ocular
surface from an inevitable passive, degenerative process to an active, inflammatory and immune-
mediated status that can be targeted, thus opening venues to prevent deleterious age-related dry eye.

Public health relevance
With increased life expectancy, debilitating diseases that accompany aging are also expected to rise, and one of them is dry eye disease. We hypothesize that age-related increase in cathepsin S participates in age-related dry eye by generating auto-reactive T cells. The overall goal of this proposal is to define the mechanisms of how cathepsin S modulation can improve ocular health.